Geisinger Cancer Institute - NCI Community Oncology Research Program (NCORP)

Project Summary/Abstract
The Geisinger Cancer Institute NCI Community Oncology Research Program (Geisinger Cancer Institute
NCORP) builds upon a strong foundation of cancer research from our rich experience with National Cancer
Institute (NCI) research collaborations. Participation with the NCI NCORP in its mission to create a national
integrated research network of cancer prevention, control, screening/post-treatment surveillance, treatment
and imaging clinical trials, as well as cancer care delivery research, is supported by our NCORP Community
Site through the follow aims. (1) To provide an optimal portfolio of clinical research and cancer care delivery
research in Geisinger service areas. With NCORP/NCTN trials as the cornerstone of the portfolio, we will work
in partnership with NCORP participants, NCI Oncology Groups and research bases to activate, recruit subjects
and complete trial requirements to advance cancer care and patient outcomes. Using processes and practices
developed as an established NCORP Community Site and a centralized management and leadership, we will
implement clinical trials at the primary affiliate and sub-affiliate sites, which will allow our team of investigators
to access, open and increase the accrual of patients to NCTN supported trials. (2) To serve rural and medically
underserved patient populations close to home, and as convenient as possible, by providing oncology clinical
research through a network of distributed community-based locations in the Geisinger Cancer Institute
NCORP. We strive to build trusted relationships with local community programs and leaders whose missions
serve a mix of racially, ethnically and culturally diverse populations. (3) To develop a continually improving
infrastructure and seamless environment for conducting clinical trials and cancer care delivery research. We
draw upon Geisinger's integrated delivery system structure, employed physician network and advanced
information technology capabilities to institute practices, systems and policies to enhance our Geisinger
Cancer Institute NCORP Community Site and share those successes with NCI leadership and other
participating NCORP Community Sites. (4) To leverage Geisinger's organizational expertise and experience in
the areas of population health, health information technology, and healthcare value-based re-engineering to
contribute towards the rapid advancement of cancer care delivery research at NCORP Research Bases.

Public health relevance
Project Narrative The Geisinger Cancer Institute NCI Community Oncology Research Program (Geisinger Cancer Institute NCORP) builds upon a strong foundation of cancer research from our rich experience with National Cancer Institute (NCI) collaborations. The goals of the Geisinger Cancer Institute NCORP are to work in partnership with the NCI NCORP network to bring cancer clinical trials (cancer control, prevention, screening, treatment, and imaging), as well as cancer care delivery research, to individuals in their own communities, thus generating a broadly applicable evidence base that contributes to improved patient outcomes and a reduction in cancer disparities.